HIV Drug Resistance, Monitoring and Transmission

HIV Drug Resistance, Monitoring and Transmission Rami Kantor, MD
SUMMARY
My career passions have always been mentoring in and conducting HIV-related patient oriented research. I’ve
developed a multidisciplinary research portfolio, combining patient care with clinical, laboratory and
bioinformatics translational research, in national and international settings. This diverse range will provide the
basis for this Mid-Career Investigator award, and will offer plenty of opportunities for mentoring and research. I
have mentored numerous trainees at various stages and settings, including post-doctoral fellows and junior
faculty, which resulted in presentations, publications, grant productivity and career developments. My research
focus has always been HIV in adults and children, specifically focused on drug resistance, treatment
monitoring and transmission. My two current R01s, my laboratory, the Providence-Boston Center for AIDS
Research, the very strong institutional commitment, and the outstanding infrastructures at Brown University
and its affiliated hospitals, including federally funded training Programs and Centers, will all serve as strong
sources, resources and foundation for this K24, and will provide exceptional capacity and a multidisciplinary
platform for mentees. Building on my research expertise and current R01 funding, the Research Specific Aims
of this K24 are to (1) Investigate HIV drug resistance and its global impact (supported by R01AI108441);
(2) Optimize treatment monitoring of HIV-infected patients (supported by R01AI120792); and (3) Use
phylogenetic inference to halt HIV transmission (supported by this K24). The Mentoring Specific Aim of this
K24, that will accompany all research Aims, is to mentor new investigators in multidisciplinary patient
oriented research. I will accomplish these Aims by recruiting passionate, committed and potent individuals
from the rich local infrastructure, and using my diverse research portfolio to develop specific and individual
mentoring plans for them to match their short and long-term goals. Based on specific projects on HIV drug
resistance, monitoring and transmission, mentees will receive training on topics like generation of research
ideas, obtaining funding and human subjects approvals, study and protocol design, staff recruitment and
training, patient enrollment, sample collection, laboratory assays and experiments, and data analysis,
presentation and dissemination. This K24 will provide 50% of my salary and additional funds to support
mentees’ research, as well as protected time for my own development towards becoming a better researcher
and mentor. Augmented by my own, continuous, immediately available NIH-funded research support and
institutional funds, this K24 will support me to increase the pool of well-trained clinical researchers of the future
and to mentor a new generation of junior investigators in HIV related patient oriented research towards their
independence.

Public health relevance
HIV Drug Resistance, Monitoring and Transmission Rami Kantor, MD NARRATIVE This Mid-Career Investigator Award will allow me protected time to mentor junior investigators in patient oriented research, focused on the globally-important public health topics of HIV drug resistance, treatment monitoring and transmission, while pursuing my research agenda.